Transportability Methods to Extend Inferences from Contemporary Type 2 Diabetes Clinical Trials to Veterans

7\SH GLDEHWHV PHOOLWXV 7' LV D FRPPRQ FKURQLF GLVHDVH DVVRFLDWHG ZLWK PRUELG DQG FRVWO\
FRPSOLFDWLRQV LQFOXGLQJ FDUGLRYDVFXODU GLVHDVH DQG FKURQLF NLGQH\ GLVHDVH ± WRJHWKHU UHIHUUHG WR DV
FDUGLRUHQDO FRPSOLFDWLRQV 1HZ PHGLFDWLRQ FODVVHV ± JOXFDJRQOLNH SHSWLGH UHFHSWRU DJRQLVWV */35$ DQG
VRGLXPJOXFRVH FRWUDQVSRUWHU LQKLELWRUV 6*/7L ± KDYH SURYHQ FDUGLRUHQDO EHQHILWV LQ LQGLYLGXDOV ZLWK 7'
9HWHUDQV KDYH D KLJKHU SUHYDOHQFH RI 7' WKDQ WKH JHQHUDO SRSXODWLRQ RI 86 DGXOWV DQG 9HWHUDQV ZLWK 7'
KDYH D KLJKHU SUHYDOHQFH RI FDUGLRUHQDO FRPSOLFDWLRQV WKDQ QRQ9HWHUDQV ZLWK 7' 7KXV HYLGHQFH LQ
9HWHUDQV ZLWK 7' UHJDUGLQJ WKH HIIHFWV RI */35$ 6*/7L DQG DOWHUQDWLYH JOXFRVHORZHULQJ PHGLFDWLRQV RQ
JO\FHPLD DQG FDUGLRUHQDO FRPSOLFDWLRQV PD\ KDYH VXEVWDQWLDO LPSOLFDWLRQV IRU 9$ 7' FDUH +RZHYHU
9HWHUDQV DUH LQIUHTXHQWO\ SDUWLFLSDQWV LQ LQIOXHQWLDO UDQGRPL]HG FOLQLFDO WULDOV 5&7V RI 7' PHGLFDWLRQV
FUHDWLQJ D FULWLFDO HYLGHQFH JDS ZKHWKHU WKH UHVXOWV RI 5&7V RI */35$ 6*/7L DQG RWKHU JOXFRVHORZHULQJ
PHGLFDWLRQV DUH H[WHUQDOO\ YDOLG LQ 9HWHUDQV ZLWK 7'
7KH RYHUDOO JRDO RI WKH SURSRVHG VWXG\ LV WR XVH ELRVWDWLVWLFDO WRROV NQRZQ DV WUDQVSRUWDELOLW\ PHWKRGV WR
SURMHFW HIIHFWV IURP UHFHQW 5&7V RI 7' WUHDWPHQW WR 9HWHUDQV ZLWK 7' DQG WR HYDOXDWH WKH LPSDFWV RI
GLIIHUHQW WUHDWPHQW SROLFLHV RQ FDUGLRUHQDO FRPSOLFDWLRQV LQ 9HWHUDQV DQG V\VWHPZLGH FRVWV 7KH FKDOOHQJH RI
DVVXPLQJ 5&7 UHVXOWV DSSO\ WR SRWHQWLDO UHDOZRUOG XVHUV RI D PHGLFDWLRQ ZKR ZHUH QRW 5&7 SDUWLFLSDQWV LV WKDW
GLIIHUHQFHV LQ EDVHOLQH FKDUDFWHULVWLFV FRXOG PRGLI\ WKH WUHDWPHQW HIIHFW REVHUYHG LQ WKH WULDO OHDGLQJ WR LQYDOLG
LQIHUHQFH RI WKH WUHDWPHQW HIIHFW LQ WKH UHDOZRUOG SRSXODWLRQ 7UDQVSRUWDELOLW\ PHWKRGV UHZHLJKW LQGLYLGXDO
OHYHO 5&7 GDWD WR EDODQFH EDVHOLQH FKDUDFWHULVWLFV EHWZHHQ 5&7 SDUWLFLSDQWV DQG D WDUJHW SRSXODWLRQ ± LQ WKLV
FDVH 9HWHUDQV ZLWK 7' ZKR PHHW 5&7 LQFOXVLRQH[FOXVLRQ FULWHULD 3ULRU ZRUN IURP WKH LQYHVWLJDWRU WHDP KDV
GHPRQVWUDWHG WKH YDOLGLW\ RI WUDQVSRUWDELOLW\ PHWKRGV DFURVV D UDQJH RI GDWD VHWWLQJV DQG VKRZQ WKDW WKHVH
PHWKRGV FDQ DFFXUDWHO\ SURMHFW WUHDWPHQW HIIHFWV IURP RQH VWXG\ SRSXODWLRQ WR D VHFRQG 7UDQVSRUWDELOLW\
PHWKRGV WKHUHIRUH SURYLGH D VWDWLVWLFDO WRRO WR DGGUHVV WKH HYLGHQFH JDS EHWZHHQ 5&7V DQG UHDOZRUOG FDUH
7KH SURSRVDO IRFXVHV RQ ILYH UHFHQW 5&7V LQ LQGLYLGXDOV ZLWK 7' *5$'( &$19$6 (03$5(*
287&20( /($'(5 DQG 6867$,1 *5$'( FRPSDUHG IRXU PHGLFDWLRQV DV VHFRQGOLQH WUHDWPHQW IRU 7'
LQ LQGLYLGXDOV ZLWK LQDGHTXDWH JOXFRVH FRQWURO RQ PHWIRUPLQ DORQH ± D YHU\ FRPPRQ FOLQLFDO VFHQDULR LQ WKH 9$
&$19$6 DQG (03$5(* 287&20( H[DPLQHG FDUGLRYDVFXODU DQG UHQDO RXWFRPHV DVVRFLDWHG ZLWK WKH
6*/7L FDQDJOLIOR]LQ DQG HPSDJOLIOR]LQ UHVSHFWLYHO\ WKH ODWWHU EHLQJ WKH PRVW FRPPRQO\ SUHVFULEHG 6*/7L LQ
WKH 9$ /($'(5 DQG 6867$,1 H[DPLQHG FDUGLRYDVFXODU DQG UHQDO RXWFRPHV DVVRFLDWHG ZLWK WKH */35$
OLUDJOXWLGH DQG VHPDJOXWLGH UHVSHFWLYHO\ ± WKH WZR PRVW IUHTXHQWO\ XVHG */35$ LQ WKH 9$ $LP ZLOO SURYLGH
HIIHFW HVWLPDWHV RI */35$ 6*/7L DQG DGGLWLRQDO JOXFRVHORZHULQJ PHGLFDWLRQV RQ JO\FHPLF DQG
FDUGLRUHQDO RXWFRPHV EDVHG RQ WKHVH ILYH 5&7V WUDQVSRUWHG WR all trial-eligible Veterans with T2D ,Q $LP WKH
WDUJHW SRSXODWLRQV DUH QDUURZHG WR VXEJURXSV RI 9HWHUDQV EDVHG RQ DJH DQG HOHYDWHG ULVN RI FDUGLRUHQDO
FRPSOLFDWLRQV WR JDLQ LQVLJKW LQWR potential benefits of prioritizing specific subgroups of Veterans for treatment
with GLP1RA and SGLT2i $LP HVWLPDWHV WKH QXPEHU RI FDUGLRYDVFXODU HYHQWV SUHYHQWHG DQG 9$ V\VWHP
ZLGH FRVWV XQGHU GLIIHUHQW WUHDWPHQW SROLFLHV ± WUHDW DOO HOLJLEOH 9HWHUDQV YHUVXV SULRULWL]LQJ VSHFLILF VXEJURXSV
7KLV VWXG\ LV LQQRYDWLYH LQ LWV DSSOLFDWLRQ RI HPHUJLQJ ELRVWDWLVWLFDO WRROV ± WUDQVSRUWDELOLW\ PHWKRGV ± WR
DGGUHVV D JDS LQ DFWLRQDEOH HYLGHQFH EHWZHHQ LQIOXHQWLDO 5&7V ZLWK IHZ 9HWHUDQ SDUWLFLSDQWV DQG FRPSDUDWLYH
HIIHFWLYHQHVV UHVHDUFK VWXGLHV LQ 9HWHUDQV *LYHQ WKH SRWHQWLDOO\ EURDGHU DSSOLFDWLRQV RI WUDQVSRUWDELOLW\
PHWKRGV WKH VWXG\ LV SRLVHG IRU ODVWLQJ LPSDFW E\ SURYLGLQJ DQ DQDO\WLF URDGPDS DQG DFFRPSDQ\LQJ VWDWLVWLFDO
FRGH DQG SLSHOLQH WR IDFLOLWDWH WKH XVH RI WKHVH PHWKRGV LQ WKH 9$ LQ RWKHU GLVHDVHGUXJ FRQWH[WV LQ WKH IXWXUH

Public health relevance
While new medication classes promise to transform diabetes care and reduce diabetes complications, there remains limited evidence of their effects in Veterans with type 2 diabetes. This is largely because Veterans are not well-represented in randomized clinical trials, and Veterans often differ from clinical trial participants across many clinical and demographic characteristics, exacerbating the challenge of generalizing trial results to Veterans. Recent advances in biostatistical methods offer tools for bridging this evidence gap between clinical trials and real-world patient populations. We propose to apply these methods, called transportability methods, to several recent clinical trials in type 2 diabetes to generate valid VA-specific evidence of the efficacy of contemporary diabetes treatments in Veterans. We will then use this real-world evidence in Veterans to project short-term impacts - the potential number of diabetes complications prevented, budget impact for the VA, and cost-effectiveness of different treatment strategies - that may inform VA diabetes treatment guidelines.